Functions and Activities of p53 and Mdm2 in Normal and Cancer Cells

Functions and Activities of p53 and Mdm2 in Normal and Cancer Cells.
The p53 protein, a major suppressor of cancer in animals and humans, is a DNA sequence
specific regulator of transcription of hundreds of genes whose products mediate cellular
outcomes such as cell cycle arrest, cell death, senescence, metabolic changes, DNA repair and
others that are consistent with tumor suppression. While a potent regulator of such processes in
cells undergoing various forms of genotoxic or oncogenic stress, if allowed to function
unchecked, p53 can be damaging or even lethal to cells and tissues. Keeping p53 under tight
control is therefore as important as allowing it to function when needed. The two proteins that
play the most central role in suppressing p53 are Mdm2 and its homologue MdmX. Over half of
all human malignancies (depending on the tumor type) harbor wild-type p53, which if released
from Mdm2/X, might be effective as a cytostatic or cytotoxic anti-tumor agent. Yet reagents
(peptides and small molecules) that prevent Mdm2 from binding to p53 have not yet been fully
realized as effective therapeutic agents. Similarly, there few effective drugs in the clinic that
prevent the oncogenic activities of mutant p53. Further, increasing lines of evidence document
p53-independent roles of Mdm2 and MdmX in cancer cells that can be exploited for therapeutic
and diagnostic purposes. The work proposed in this application for an Outstanding Investigator
Award follows a long history of contributions in the laboratory of the PI to our understanding
p53, Mdm2 and MdmX that continue to the present day. The plans going forward build on new
findings in the PI's lab, and incorporate novel technologies in order to gain more global and
mechanistic information about the p53/Mdm axis. The research proposed will extend recent
discoveries related to (i) a novel mechanism by which Mdm2 degrades p53 and the possibility
that this finding can lead to new therapeutics that prevent Mdm2 degradation of wild-type p53 or
conversely facilitate Mdm2 degradation of oncogenic mutant forms of p53, (ii) a series of
CRISPR-derived cell lines harboring unique Li-Fraumeni-Syndrome p53 mutations; (iii) p53-
independent roles of Mdm2 and MdmX that may either prevent or support oncogenesis, (iv)
long non-coding RNAs that are p53 targets and which may provide new biomarkers in human
cancers; (v) new approaches to understand how p53 identifies its sites in vitro and in vivo and,
(vi) examination at single molecule resolution the localization of wild-type and mutant forms of
p53 and Mdm2 after different stimuli. The long term goals of this program will hopefully lead to
new tools for diagnosis and treatment of sporadic and inherited cancers.

Public health relevance
Project Narrative This application for an Outstanding Investigator Award builds on a long history of discoveries concerning the p53 tumor suppressor protein and its negative regulators Mdm2 and MdmX in the laboratory of the Principle Investigator. The research planned will identify new ways to strengthen the roles of p53 in protecting from cancer and to prevent Mdm2 and MdmX from promoting oncogenesis. Such findings may eventually yield new diagnostic and therapeutic tools for treating cancer patients.